PURINE/PYRIMIDINE THERAPY IN A DISORDER OF NUCLEOTIDE METABOLISM

To test beneficial effects of uridine analog in patients, and to determine the potential benefit of adding oral ribose to patients who are currently on uridine therapy.